Administrative Core

Project Summary/Abstract – Administrative Core
In an effort to address fundamental questions regarding the dynamics and drivers of influenza transmission
between humans, the Administrative Core (AC) will serve as a hub for the Evaluating Modes of Influenza
Transmission using Innovative Technologies and Designs in Controlled Environments (EMIT-2) program, with
the overall objective of ensuring smooth information exchange, planning and collaboration, timely achievement
of milestones and aims for each project, appropriate availability and utilization of cores, dissemination of
results, and evaluation of the research products. The Administrative Core will provide leadership and direction
for the proposed work, and orchestrate the activities of the investigators in the projects and cores to achieve
the program aims and to produce an integrated research program that is more than merely the sum of the
parts. To achieve the goals of the proposed EMIT-2 Program, the AC has the following aims: Aim 1:
Contribute overall leadership, expertise, and an administrative structure that fosters communication and
collaboration among program cores and projects, resulting in enhanced synergy and success. Aim 2:
Provide accountability and sound fiscal management of the program cores and projects to promote
efficient use of resources to achieve program milestones in a timely manner, through the completion of
monthly, standardized financial and scientific reports documenting project or core progress towards milestone
achievement and tracking spending. Aim 3: Develop and support approaches to encourage and facilitate the
dissemination of program resources, methods and results to all stakeholders to advance the field. To further
advance the field, we will ensure the dissemination of results in language appropriate to a wide audience with
varying levels of education. A principal responsibility of the Administrative Core will be to evaluate progress
toward EMIT-2 milestones and aims. Through a process of regular and frequent meetings including meetings
with the Steering Committee and Scientific Advisory Board, the AC leadership will be available to help
individual projects and investigators identify obstacles and solutions. The Core will also promote and evaluate
the program’s impact through tracking of publications, presentations and related grant applications of both
faculty and students.